IBUPROFEN IN TREATMENT OF JRA--A DOUBLE BLIND ASPIRIN CONTROLLED STUDY

The purpose of this project is to evaluate ibuprofen in the treatment of juvenile rheumatoid arthritis in a double blind, aspirin controlled study.